Bruker AVANCE NEO 600 MHz High-Performance Digital NMR Spectrometer

ABSTRACT This proposal requests funds for the purchase of a state-of-the-art Bruker AVANCE NEO 600 MHz high- performance digital NMR spectrometer, which will be housed in the University of Kentucky (UK) PharmNMR Center located in the College of Pharmacy. The requested spectrometer offers capabilities that exceed by far those of the existing NMR instruments currently accessible to the users of this application on campus or anywhere else in the Commonwealth of Kentucky. At UK, there is an urgent need for a high-end, high-field NMR spectrometer for biomedical researchers to be able to: (i) determine structures of small molecules (e.g., synthetic and natural products) in very low amounts as well as determine real-time kinetics; (ii) perform 19F NMR experiments; (iii) establish protein-ligand interactions and/or perform fragment-based drug screening; (iv) determine protein-protein interactions; (v) establish protein dynamics and do relaxation-dispersion experiments; (vi) perform protein structure calculations; (vii) study intrinsically disordered proteins; and (viii) run diffusion ordered spectroscopy (DOSY) experiments. All these capabilities will allow UK researchers to perform cutting- edge work in areas of interest to UK, namely natural product drug discovery and development, infectious diseases and bacterial resistance, cancer, as well as substance use and neurological disorders. The requested instrument will support a widely diverse array of collaborative translational research at UK and is expected to have an immediate and dramatic impact on the NMR-dependent research programs of its NIH-funded researchers.

Public health relevance
PROJECT NARRATIVE The acquisition of a state-of-the-art Bruker AVANCE NEO 600 MHz high-performance digital NMR spectrometer will greatly enhance the research of NIH-funded investigators at the University of Kentucky by providing cutting- edge research capabilities currently not easily accessible or affordable on campus or anywhere else within the Commonwealth. This NMR spectrometer will provide a drastic increase in sensitivity and resolution along with the ability to study biomolecules and conduct experiments on very small (microgram) quantities of small molecule samples.